Directing Tryptophan Immunometabolism to Ameliorate Liver Ischemic-Reperfusion Injury

Project Summary/Abstract
Many different disease states and surgical interventions result in a period of inadequate
tissue/organ blood supply (i.e., ischemia), that result in reperfusion injury when blood flow is
restored, known as ischemia-reperfusion injury (IRI). IRI causes local inflammation, cell death,
excessive tissue destruction and possible organ failure. Examples are found in transplantation,
trauma, myocardial infarction, stroke, and in particular, IRI is a main cause of liver dysfunction
and failure after liver surgery. Unfortunately, there are currently no therapies available in clinical
practice addressing IRI, where a major problem is the harmful systemic side effects and toxicities
of existing drugs.
To address this problem, we are innovating a new therapeutic technology aiming to program
immune cells toward a metabolic state blocking excessive inflammation by directing tryptophan
metabolism through delivery of an enzyme into circulation. This represents a new class of anti-
inflammatory/immunosuppressive biologic drug, with potential to limit systemic toxicities/side
effects, and with potential to be significantly less immunocompromising. Lack of treatment options
for liver IRI and a catalog of in vivo preliminary data strongly supporting the foundational rationale
of IDO as an innovative new anti-inflammatory agent, make this proposal highly significant.
Looking to the future, success would open opportunity to expand to other anti-inflammatory
applications, for example, pre-conditioning donor grafts for transplantation.

Public health relevance
Project Narrative We have developed an innovative new enzyme-based therapeutic technology to shut down inflammation. As an injectable into the bloodstream, this new type of drug is showing great promise for the treatment of liver ischemia-reperfusion injury, which is a major clinical problem lacking treatment options.